Preventing hospitalizations for COPD exacerbations due to air pollution from wildfire smoke

PROJECT SUMMARY
This K23 will provide Laura Myers MD, MPH with time and resources to pursue additional training to become
an independent investigator and leader in mitigating environmental harms in diverse patients with chronic
obstructive pulmonary disease (COPD). Dr. Myers is a Harvard-trained, board certified pulmonary/critical care
physician and Assistant Professor-level researcher at the Kaiser Permanente Northern California Division of
Research. COPD exacerbations are associated with worse mortality and quality of life and account for 65% of
COPD-related health care costs ($18B/year). There is an urgent need to identify patients at high-risk of
hospitalization for COPD exacerbations and find effective interventions. Up to 30% of COPD exacerbations are
due to particulate matter air pollution (PM2.5, where ≤2.5µm refers to particle diameter). A growing fraction
(>20%) of PM2.5 comes from wildfires, which is considered more toxic than PM2.5 from other sources. PM2.5
disproportionately enters the homes of people with low socioeconomic status (SES) through poor
sealing/ventilation systems. An expert panel has identified a critical knowledge gap, lack of evidence on
effectiveness of interventions, such as indoor portable air cleaners, in the wildfire setting. In this proposal, Dr.
Myers will complete the following aims: 1) develop and externally validate a prediction model that incorporates
geocoded air pollution and wildfire smoke data to identify patients at highest risk of hospitalization for COPD
exacerbation, 2) identify modifiable barriers to and facilitators of interventions that mitigate exposure to air
pollution from wildfires in COPD patients with low SES, and 3) conduct a 2-arm, randomized controlled pilot of
a multimodal intervention to mitigate exposure to air pollution from wildfires in high-risk COPD patients with low
SES. Dr. Myers proposes 4 training aims to gain: 1) advanced training in prediction modeling methods using
geocoded air pollution variables as predictors, 2) training in qualitative methods, 3) methodologic expertise in
designing and executing a clinical trial, and 4) deeper understanding of the social determinants of health and
health equity. This research is significant because reducing hospitalizations for COPD exacerbations due to air
pollution from wildfire smoke would improve patients’ quality of life, long-term clinical outcomes and healthcare
costs. This research is innovative because a scalable, non-pharmacologic, evidence-informed intervention (air
cleaners) is applied to a new setting (wildfires) as part of a multimodal intervention, using an ideal testbed
(planned burns within a large catchment area). The work will provide preliminary data for an R01 to test a
multimodal intervention in high-risk patients with COPD and low SES during active wildfires. The results of
future work could lead to policy changes, as demonstrating effectiveness of an intervention could make the
equipment more accessible to patients. The proposal builds on Dr. Myers’ clinical background as a
pulmonologist and previous MPH work. It leverages access to unparalleled longitudinal data for >4.5 million
patients, a world-class mentoring team and advanced analytic training at UC San Francisco and Berkeley.

Public health relevance
PROJECT NARRATIVE Wildfire smoke is toxic air pollution that disproportionately impacts those with low socioeconomic status. The goal is to mitigate exposure of high-risk patients with chronic obstructive pulmonary disease and low socioeconomic status to wildfire smoke in order to prevent hospitalization and improve health equity.